DREAMS - Admin Core

The DREAMS-CDTR activity is overseen by its Administrative Core, which coordinates and manages all Center activities across its Translational Research and Resource Cores. The role of the Administrative Core is to 1) ensure the scientific productivity and collaboration of DREAMS Center Core faculty members through support and oversight of the translational research and resource cores, as well as the pilot and feasibility and enrichment programs; 2) encourage collaboration between the DREAMS Center members, the CDTR and Diabetes Research Centers, and with NIDDK; 3) grow the reach and impact of the center; and 4) review, evaluate, and update Center activities in close collaboration and consultation with the DREAMS Center Internal and External Advisory Committees.